Novel Approaches for Predicting Unstructured Short Periods of Physical Activities in Youth

? DESCRIPTION (provided by applicant): The use of accelerometers for the measurement of physical activity in youth has increased substantially over the last decade. Accelerometers are typically worn on the waist, however recently alternative placement sites such as the wrist have become more popular. For example, the National Health and Nutrition Examination Survey (NHANES) is currently using the wrist location for their accelerometer physical activity measurements. Currently there is a lack of information about best approaches for analyzing accelerometer data from the wrist location with the ActiGraph accelerometer. In addition, advances in accelerometer technology allow for utilization of the raw acceleration signal with machine learning algorithms, which have the capability to predict activities and improve the estimates of energy expenditure over previously used methods. Members of this research group have shown improved activity classification and energy expenditure prediction in youth using Bipart, versus commonly used approaches such as Artificial Neural Networks and Support Vector Machine. However, this preliminary work was based on accelerometer count data and structured lab activities with only a hip worn accelerometer. In addition, there are limitations to applying lab based models to true free-living activity. For example, free-living activity is not performed in structured bouts rather it is performed in micro-bouts over the course of the day which is problematic for methods designed to look at a string of data over a specified time period. There is minimal work currently on how to first segment bouts of free-living activity before classifying activity type and predicting energy expenditure. This proposal will extend our previous work using more advanced methods to analyze raw acceleration data (80 Hz) using a single wrist or hip worn accelerometer. One hundred youth will be measured during a semi-structured simulated free-living period (development group) and 200 youth will be measured during true free-living activity during an after-school program and at home (validation group). Measurements will include indirect calorimetry for energy expenditure and direct observation for activity type. The specific aims of the study are to: 1) develop and validate machine learning algorithms to segment bouts of activity during free-living activity in youth using: A) a hip worn accelerometer or B) a wrist worn accelerometer, and 2) develop and validate machine learning algorithms to classify physical activity type and estimate energy expenditure in youth, during free-living activity using: A) a hip worn accelerometer or B) a wrist worn accelerometer. Results from these studies will have direct and immediate impact for physical activity researchers utilizing accelerometers as well as analysis of NHANES wrist accelerometer data by providing ac- curate and precise methods for bout segmentation, prediction of activity type and energy expenditure.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will develop and validate machine learning algorithms using raw accelerometer data collected at the hip or wrist for use in youth. These algorithms will be able to detect the start and end times of free-living physical activity bouts, classify the type of activity being performed, and estimate energy expenditure, significantly improving upon current methods. These algorithms will have direct benefit to those examining dose response relationships between sedentary behaviors, physical activity and health outcomes in youth, in the physical activity and public health fields.